Optimizing Efforts to Restore Psychiatric and Social Function After a Major Hurricane

PROJECT SUMMARY/ABSTRACT
The 2017 fall Atlantic hurricane season, including Hurricane Harvey, was the most extreme in recorded history,
and, in light of global climate change, a possible harbinger of future seasons to come. It is increasingly critical
to understand how potentially modifiable pre-, peri-, and post-hurricane factors shape the long-term mental
health of affected populations, so that we may optimize interventions to limit the ultimate impact of such
storms. Individual-level experiences during and after hurricanes – such as displacement and job loss – shape
post-hurricane mental health, but a better understanding of how these individual-level events interact with
community-level factors to produce outcomes could help us to further tailor treatment approaches for
individuals and communities in disaster settings. Critically, very little is known about the effects of hurricane
relief efforts – including housing and income assistance – on longer-term outcomes. We will address these
gaps using a pre-, peri-, and post-hurricane framework to organize the influences of exposure characteristics
and sequencing on mental health outcomes. In our first aim, we will characterize how interactions among pre-
hurricane capacities (e.g., social capital) and vulnerabilities (e.g., poor housing quality) as well as peri-
hurricane stressors (e.g., power outages) and protectors (e.g., efficient government responses) – at both
individual and community levels – shape post-hurricane depression and posttraumatic stress disorder. In our
second aim, we will identify and test the effects of hypothetical interventions on post-hurricane mental health
through discrete stochastic simulations, under varying profiles of pre-, peri-, and post-hurricane capacities,
vulnerabilities, stressors, and protectors derived from aim 1. The primary goal of this proposed project is to
build on and validate prior simulation analyses to create a set of first-in-class simulation models to identify
optimal approaches to mental health services following natural disasters, and to project their public health
impact. To achieve these aims, we will geographically sample and survey individuals who lived in Hurricane
Harvey-affected areas of Texas about their experiences, incorporating a recall validation subsample with
previously collected pre-hurricane data. We will also capitalize on archival data by collecting variables at the
community level such as income inequality measures, quality of built environment, and hurricane exposure
indicators, to perform multilevel analyses across varying geographic levels. Finally, we will leverage data from
our de-novo survey to create synthetic populations with varying combinations of pre-, peri-, and post-event
factors, and use data from an ongoing post-hurricane randomized control trial to calibrate and validate
simulation models. Such in-silico experiments will shed light on the effectiveness of candidate interventions
and help us to understand their potential benefits, including comparative treatment- and cost-effectiveness.
This project will bring together an experienced team using novel methods to tackle an essential and timely
public health problem, the implications of which may also be extended to other types of disasters and contexts.

Public health relevance
PROJECT NARRATIVE As natural disasters increase in intensity and number over time, it is becoming critical to understand how potentially modifiable individual-level and community-level factors shape the long-term mental health of affected populations, so that we may intervene to optimize mental health treatment approaches and limit long- term disaster impact. We propose to study the joint effects of multilevel Hurricane Harvey-related exposures on depression and posttraumatic stress disorder, and to build first-in-class simulation models that will illuminate the potential benefits and comparative treatment- and cost-effectiveness of candidate interventions, using a pre-, peri-, and post-hurricane framework. Overall, this study will help elucidate the interplay between mutable individual-level and community-level factors on mental health in post-disaster settings – data that are urgently needed and that can be used in disaster settings to inform the tailoring and treatment planning of mental health services for individuals and communities.